Feeding Readiness and Progression in Preterms Scale

[unreadable] DESCRIPTION (provided by applicant): No objective measures for bottle feeding readiness or progression to full feeding for the preterm infant exist. Preterm infants are often encouraged to bottle feed before they are ready. Consequently, they are subjected to a trial-and-error approach that may actually increase stress and detract from success. Decision-making during this process is most often intuitive and seldom takes into account other physiologic and behavioral variables. To date, maturation and severity of illness have been studied independently but little is known about the inter-relationships between these and other physiologic and behavioral variables and feeding readiness in preterm infants. The development of a reliable and valid measure sensitive to both bottle feeding readiness and progression will provide a basis for design and evaluation of interventions. The Feeding Readiness and Progression in Preterms Scale (FRAPPS) (McGrath, 2001) is a 10 item pen-and- paper instrument that has been designed to quickly assess a variety of physiologic and behavioral parameters that appear to influence bottle feeding readiness/progression in the preterm infant. Content and face validity have been established. Pilot work evaluating construct validity has also been completed. This research with 50 preterm infants will examine other parameters of construct validity as well as establish the clinical utility of the tool. Thus, the specific aims of this project are to: (1) Examine the reliability, and validity of the FRAPPS and the FRAPPS using the BioPack system integrated with the Medoff-Cooper Sucking Apparatus to collect physiologic and sucking measures of stability as correlates for feeding success and, (2) Examine the FRAPPS variables and their relationships to provide objective measures of bottle feeding readiness and progression (improvement made towards full bottle feeding) in preterm infants. Data analysis will be correlational in design and will be directed toward establishing reliability and validity of the tool. Measures of construct validity will include correlations with other measures and logistic regression. [unreadable] [unreadable] [unreadable] [unreadable]